Longitudinal Imaging and Liquid Biopsy Markers of Prostate Cancer Radiotherapy Outcomes

ABSTRACT
For intermediate and high risk prostate cancer patients who are candidates for radiotherapy (RT), the
only recognized early clinical response indicator is serum PSA level. There are some risk features used for
treatment intensification, but optimized criteria are lacking for recommendations concerning the use and length
of androgen deprivation therapy (ADT), and the use of additional systemic agents (e.g., abiraterone,
chemotherapy). Approximately 30-40% of patients diagnosed with unfavorable intermediate to high risk
nonmetastatic prostate cancer will develop biochemical or clinical progression within 5 years and about half of
men with distant metastasis from prostate cancer originated from these groups. There is a critical unmet need
to better define risk of progression such that treatment intensity is optimized and progression prevented.
We propose to define the role of quantitative multiparametric MRI (mpMRI) features in combination with
Circulating Tumor Cells (CTCs) as early markers of patient outcome after RT ± ADT in unique longitudinal
clinical studies strategically carried out at the University of Miami and in an external radiotherapy validation
cohort from the NCI. Our proposal addresses the problem of prostate tumor heterogeneity by applying an
mpMRI 10 point pixel-by-pixel automated habitat risk score (HRS) classification system based on spatially
distinct tumor/microenvironment characteristics. The habitat concept was introduced to map and adjust for
tumor heterogeneity. The established “absolute” scale of HRS is ideal for monitoring changes longitudinally
while reducing MRI vendor effects. In addition, we will apply more detailed quantitative features in models that
link the changes in habitat composition and radiomics to liquid biopsy information and clinical outcome
measures. The primary early endpoint is freedom from biochemical nadir thresholds at 9 months (FFBN9mo).
The secondary longer term endpoint is time to Biochemical and/or Clinical Disease Failure (BCDF).
Our group has recognized that liquid biopsy measures have the potential to improve the appraisal of
pretreatment risk and longitudinal response to treatment. As such, CTCs, quantified using a microfiltration
system, have been measured in our clinical trials at intervals before and after RT±ADT. In this application, we
will leverage the unique clinical power of several mature and ongoing prospective RT trials in which mpMRI
features (Aim 1), and CTCs (Aim 2) are collected pre-RT and at four time points post-RT. To our knowledge,
these trials constitute the largest and most exhaustive resource for investigation of the relationship between
quantitative imaging features, pre-Tx tissue genomics, liquid biopsies and RT treatment outcomes. The final
goal of the proposal is to develop a multivariable model (Aim 3) that incorporates pretreatment and longitudinal
mpMRI features and CTCs to guide physicians’ decisions about intensification and de-intensification of radiation
therapy. These models will be validated in a prospective clinical trial (the Miami UAdapt trial).

Public health relevance
PROJECT NARRATIVE There is an expanding array of risk adapted treatment options available to men undergoing primary treatment for intermediate and high risk prostate cancer; however, studies that incorporate quantitative imaging and liquid biopsy markers pre-treatment and early during treatment are lacking. In this application, we will define and incorporate the predictive power of quantitative imaging and liquid biopsy data, combined with pre-treatment tissue genomics, to develop multivariable models that incorporate pretreatment and prospectively acquired longitudinal MRI features and circulating tumor cells (CTCs). We will test prospectively how the estimated probabilities of adverse outcomes guide treatment intensification or deintensification.